Maternal Immunization and Determinants of Infant Immunity

ADMINISTRATIVE CORE – ABSTRACT
UNIVERSITY OF MARYLAND SCHOOL OF MEDICINE
Center for Vaccine Development and Global Health (CVD)
The Administrative Core for the Maternal Determinants of Infant Immunity (MADI) P01 Program Project, based
at the Center for Vaccine Development and Global Health (CVD), University of Maryland, Baltimore, will organize,
coordinate, and facilitate all administrative activities associated with the participating Projects and Cores. Led by
Dr. Marcela Pasetti, The Administrative Core will work diligently and efficiently to provide a centralized yet flexible
and responsible infrastructure to oversee, promote, and support the scientific endeavors of the Projects and
Cores. The Administrative Core will be service-oriented. Its goals will be to help investigators conduct research
of the highest quality and productivity, and to achieve and surpass the Program Project scientific goals.
Aim 1: To manage the administrative and fiscal operations of the Program Project to facilitate the
attainment of research objectives.
Administrative and fiscal responsibilities will include overseeing subcontract agreements and distribution of
funds, monitoring finances and ensuring financial efficiency, allocation and, if necessary, reallocation of
resources to meet program goals, and ensuring compliance with National Institutes of Health (NIH) and federal
and state regulations. The Administrative Core will also be responsible for financial and scientific reports.
Aim 2: To foster effective communication among investigators to facilitate integration, collaboration,
and synergy within the Program Project.
The Administrative Core will coordinate and facilitate communication among investigators and institutions and
will organize meetings to aid collaboration. Program management and collaboration tools will be used to maintain
records, organize activities, and track timelines. The Administrative Core will be the central point of contact with
NIH.
Aim 3: To monitor scientific progress, oversee effective use of Core services, and maintain internal
quality control.
Leadership of the Program Project will be provided by the Principal Investigator (Dr. Pasetti); the Executive
Committee, which includes leaders from all Projects and Cores (Drs. Marcela Pasetti, Margie Ackerman, Arnaud
Marchant, John Tsang, Galit Alter, and Anne Hoen); the Program Director (Dr. Jennifer Snyder); and an external
Scientific Advisory Board (five experts from the scientific community). The Administrative Core will support and
coordinate activities of the Executive Committee and Scientific Advisory Board, and will assist in tracking
progress of the scientific aims, optimum use of Core services and resources, and compliance with regulations.
The Administrative Core team will be diligent in identifying and addressing issues to ensure the successful
completion of the work proposed.